iLookOut for Child Abuse: Micro-learning to improve knowledge retention

PROJECT SUMMARY/ABSTRACT
The epidemic of child abuse in the U.S. (>675,000 confirmed annually) causes massive harm to
children and the adults they become. Sequelae include physical disabilities and neurological
damage, mental health problems, maladaptive behaviors, and perpetuating cycles of abuse.
Young children (ages 0–5 years) are particularly vulnerable to victimization. They account for
>75% of deaths from abuse and a greater proportion of victims than older children for all
categories of maltreatment except sexual abuse. Yet despite 8-12 million American children
being in childcare, early childhood professionals (ECPs) report fewer than 1% (~2,500) of all
substantiated cases of child abuse. Research shows that ECPs are not well-prepared to identify
at-risk children, and there is a widespread need for evidence-based interventions that improve
ECP reporting of suspected child abuse while also avoiding inappropriate reporting.
Our current 5-year study is evaluating the efficacy of an innovative educational intervention,
iLook Out for Child Abuse (iLookOut) at promoting and sustaining both knowledge and
behavior change with regard to concerns about child abuse. Grounded in an experiential
learning conceptual model, iLookOut is a multi-media, online intervention that engages
learners emotionally and cognitively using an interactive, video-based storyline that provides
education, challenges learners with decision points, and gives critical feedback. iLookOut uses
gamification strategies and simulation to promote experiential learning through problem-
solving. It also includes follow-up activities to promote retention and integration of new
knowledge and to help ECPs remain aware and engaged.
Prior studies demonstrate that iLookOut's Core Training significantly improves knowledge and
attitudes about reporting suspected child abuse and is well received by ECPs. To evaluate its
impact on sustaining knowledge and changing behavior, our current grant will administer
knowledge and behavioral measures before and after iLookOut's Core Training and its Advanced
Training. This Administrative Supplement will 1) resolve problems with data integrity by
transitioning to a new learning management system (LMS) in advance of beginning recruitment
for the current study; 2) enable iLookOut's Core Training and Micro-Learning interventions to
be deployed for the duration of the current grant period using this new LMS; and 3) help ensure
continued nationwide delivery of iLookOut programs to Head Start through the end of the
current grant period (through July 31, 2027 with an anticipated 1-year no-cost extension).

Public health relevance
PROJECT NARRATIVE This Administrative Supplement application is to establish a fully reliable learning management system (LMS) and the corresponding research database needed to fulfill the aims of our current 5-year randomized controlled trial to determine how best to sustain knowledge about child abuse and its reporting. This LMS and research database (which will include research data dashboards, analytic functionality, and multiple reporting modalities) will support iLookOut's evidence-based mandated reporter training and follow-up interactive micro-learning course about how to protect at-risk children and support them and their families. In so doing, this supplement also will help ensure continued nationwide delivery of iLookOut programs to Head Start through the end of the grant period (anticipated to be July 31, 2027).